The I SPY 2.2 TRIAL: Evolving to Imaging and Molecular Biomarker Response Directed Adaptive Sequential Treatment to Optimize Breast Cancer Outcomes

The I-SPY Program Project advances the goals of personalized treatment in the setting of an advanced clinical trial design
that facilitates continuous improvement in outcomes. In this program, we focus on women with stage 2 and 3 molecularly
high-risk, early breast cancer who have the highest risk for rapid progression and death. The I-SPY2.2 program project
allows us to generate a patient-centric approach to clinical drug development that optimizes individual, biomarker-
targeted treatments by escalation or de-escalation of therapy based on treatment response, doing so in the context of a trial
that efficiently evaluates novel potential first-line agents and treatment regimens. The lessons and insights developed in
this program project will be broadly applicable beyond breast cancer to other cancers and to clinical trial design.
The continuation of the I-SPY2.2 program project will provide the resources for the discovery research that ultimately
will increase complete response (pCR) and prevent metastases. The proposed four projects and three shared resource cores
will allow us to create strategies for combining multiple biomarker analytes from the tumor and derivatives assessed in
circulation to build better and better predictive models of lack of response and poor outcome in the neoadjuvant setting
and further identify ‘druggable’ targets in residual disease to alleviate resistance. The I-SPY program and the Program
Project have, in effect, established a continuous improvement system for breast cancer treatment outcomes, enabling us to
drive progress in precision medicine for breast cancer, importantly, using a highly patient-centric framework. The iterative
process will lead to more and better targeting of therapies by leveraging biologic insights, refinement of response-
predictive biomarkers, and integration of both efficacy and impact on quality of life. The combination of these elements
will save lives, reduce morbidity and set the stage for improved personalization and translation to clinical practice.
In the past 5 years of the I-SPY2.2 program project, we have met all of our stated aims, creating and implementing (June
2022) a novel, innovative trial design to both test novel agents and individualize care over the course of the treatment. In
the subsequent five years, we will iteratively refine the processes to optimize outcomes through early de-escalation of
treatment in the setting of success, and early escalation of treatment in the setting of minimal response, based on our
innovations in establishing and refining quantitative breast MRI as a biomarker of response assessment. We will use
integrated molecular and immune response-predictive subtypes developed in the first five years to assign treatments for
targeted agents initially without standard chemotherapeutics, but then in sequence if response is not sufficient. We will
randomize treatments based on the improved, response-predicted subtypes we developed to test their ability to precisely
assign treatments. We will use a sequential multiple assignment approach (SMART) to identify optimal sequences of
therapy and use the framework to integrate a seamless phase 2/3 trial that will speed the process of getting the most effective,
least toxic treatment strategies to women in the shortest possible time. The infrastructure of the proposed program project
and the tightly integrated, experienced multidisciplinary team that is dedicated to the goals of the program will enable us to
accomplish our goals and impact the lives of women with high-risk breast cancer.

Public health relevance
We have designed a clinical trial for women treated with drugs for early breast cancer before surgery, in which patients whose cancers do not respond to the initial experimental treatment can be switched to receive a different proven therapy that is considered the best for their particular type of cancer. Our goal is to develop a system that continuously improves our ability to provide each woman with the best chance at being cured, while also trying to avoid any unnecessary treatments that cause toxic side effects. This research program involves doctors and researchers from many different disciplines, as well as many patient advocates, to create a new type of clinical trial that puts patients needs front and center.